Kansas IDeA Network of Biomedical Research Excellence (K-INBRE) - suppl WH

ABSTRACT
Title of the supplement proposal: “Progesterone promotes breast cancer immune evasion through
downregulation of antigen presentation”
Approximately 75% of all breast cancers (BC) are classified as hormone receptor positive (HR+), the majority
expressing both the Estrogen and Progesterone Receptors (ER/PR). Although several classes of anti-estrogen
endocrine therapies exist for these cancers, ~30% of women with ER+ breast cancer will develop resistance and
die from metastatic disease. Thus, new therapeutic targets and strategies are desperately needed for the
treatment of endocrine-resistant disease. While existing therapies target ER pathways, there are currently no
clinical means to target PR, despite multiple studies implicating PR in progression outcomes in HR+ BC. This
may be due to a lack of knowledge in how PR contributes to BC progression. Our recent studies have
unexpectedly revealed a significant immune modulatory role for PR. Our hypothesis is that progesterone,
working through the progesterone receptor (PR), downregulates antigen processing and presentation (APP),
thus allowing for PR-positive breast tumor escape from immune recognition and clearance by CD8+ T cells. We
will test this hypothesis with the following Specific Aims: 1) Does PR signaling downregulate the expression of
genes involved in antigen processing and presentation? 2) Does PR activation promote decreased antigen
presentation and tumor cell killing by CD8+ T cells? 3) Does PR activation lead to decreased antigen
presentation and increased mammary gland tumor growth in vivo? First, we will determine the timeline through
which PR/progesterone downregulates APP gene expression and use ChIP assays to determine if PR-
dependent downregulation of APP genes is mediated through direct binding of PR to regulatory regions of APP
genes. Second, using T cells from T cell receptor (TCR) transgenic mice, we will determine if PR-mediated
downregulation of APP genes translates to decreased antigen presentation in MHC Class I molecules and
subsequent protection from T cell-mediated tumor cell killing. Third, to determine if these phenotypes translate
to protection from mammary tumor cell killing in vivo, we will determine how treatment with progesterone and
anti-progestins (blocking PR activation) impacts syngeneic mammary tumor growth and recognition by CD8+ T
cells in vivo. Completion of these Specific Aims will determine how PR downregulates antigen presentation and
recognition by CD8+ T cells, and if this effect can be reversed using anti-progestins. These experiments will
provide new insight into the function of PR, an essential but understudied protein in breast cancer. Blocking PR’s
activity could lead to new therapeutic strategies for ER/PR-positive tumors that progress on treatment with
current ER/estrogen-based therapies.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The proposed research is relevant to public health because it seeks to mechanistically understand how progesterone receptor contributes to tumor immunosuppression and how targeting its signaling might allow for effective novel therapies in breast cancer. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to developing innovative research strategies and their application to protect and improve human health.